LEARNED MODIFICATION OF VISCERAL FUNCTION IN ANIMALS

This project investigates the role of the central nervous system in the regulation of the circulation. Instrumental conditioning is used to directly modify cardiovascular responses. Naturally-occurring, adaptive responses are examined by monitoring